Defining the Neural Circuits for Vocal Memory and Imitation

PROJECT SUMMARY
A significant portion of our behavioral repertoire is initially learned by imitating the behaviors of our parents and
other people we interact with while we are young. This is particularly evident when we consider the development
of social skills and communicative behaviors like speech and language. Understanding how the brain encodes
and retains the memories of social/vocal models that are used to guide accurate imitation is a major scientific
challenge. The goal of this research is to identify the cell types and synaptic pathways that encode memories
used for learning vocalizations and to map synaptic plasticity mechanisms underlying how these memories are
formed in the brain. Studying these memories in the laboratory is complicated by the social nature of their
acquisition and the difficulties in isolating discrete and quantifiable imitated behaviors in conventional model
species. For example, rodents and non-human primates do not appear to imitate skilled communicative
behaviors like vocalizations, but rather communicate using largely innate vocal repertoires. Zebra finches, like
people, require social experience from vocal models to form memories used to subsequently guide learning of
their courtship song. Unlike some other songbirds, zebra finches do not learn well from passive playback of
songs or triggered playback of tutor songs. The study of zebra finch song learning has therefore provided the
principal laboratory model for understanding how neural circuits encode memories from social-vocal models that
are used to guide precise motor imitation. Research over the last several years demonstrates that the premotor
song region HVC is essential for encoding song memories. Yet, neither the neuronal subtypes within HVC nor
the presynaptic input pathways necessary for memory encoding have been identified. Using methods for cell-
type specific memory manipulation, synaptic connectivity and plasticity mapping, and closed-loop optical
inhibition we will define the synaptic pathways encoding song memories and how these memories are
synaptically used to guide vocal imitation. In the first aim, we will use optogenetic tools for memory erasure to
identify cell subtypes encoding tutor song memories. In the second aim, we will describe the synaptic connectivity
and plasticity mechanisms underlying memory formation in these same circuits. In the third aim we will use
closed loop silencing of these synaptic pathways to examine the necessity of individual nodes of the circuit in
forming vocal memories and vocal imitation. Building on a suite of cutting-edge methods we have developed for
use in zebra finches and extensive new data mapping the long-range synaptic connectivity in the songbird brain,
this research will identify core circuit mechanisms for forming memories necessary for vocal imitation.

Public health relevance
PROJECT NARRATIVE We learn to imitate social and communicative behaviors during development with seemingly minimal effort. Memories of social models used to guide imitation represent an essential yet still poorly understood memory system. The overarching goal of this research program is to identify the cellular and synaptic mechanisms for encoding the memories that guide imitation.